A Smart Semiconductor based Integrated Continuous Diabetes Monitoring Platform

PROJECT SUMMARY
The long-term goal of this project is to develop a scalable, user-friendly, continuous diabetes monitoring
(CDM) system to minimize the risk of diabetic ketoacidosis (DKA) for millions of diabetes patients,
especially those with type I diabetes by adding continuous ketone monitoring (CKM) to the IMS
continuous glucose monitor (CGM). IMS has developed the world's smallest wireless electrochemical
CGM using a novel semiconductor (CMOS) platform. This design offers some unique advantages due
to its smart sensor (compared to passive sensors in competitor designs) including extreme
miniaturization (system is smaller than half a sesame seed), on-chip integration of multiple sensors,
improvement in signal-to-noise ratio (thus improving hypoglycemia accuracy), decrease in sensor
capacitance and membrane thickness (thus improving response speed), and on-chip temperature
calibration. This system can enable automatic closed-loop glucose control without meal announcements
and carbohydrate counting and without the fear of missed hypoglycemic events; greatly simplifying
patient experience and improving safety.
We have demonstrated the function of our CGM platform in the lab, in animals, and recently in humans.
The addition of CKM can significantly improve the value of the system to detect impending DKA that
goes unnoticed with the current CGM systems, causing significant harm to the at-risk patients.
Therefore, our objective in this proposal is to develop a multi-analyte sensing platform that can sense
both glucose and ketone in the interstitial fluid (ISF) using a single device. The sensing platform will be
tested both in the lab and in a porcine model (matches well with human skin and metabolism).
This research is significant as it will enable the first CDM system with a small, pain-free needle-
insertion (26-gauge needle) that can work for a long time (>30 days). Once proven, this system can be
extended to include other important analytes (e.g., insulin, glucagon) without increasing its size or
complexity, owing to on-chip integration of multiple sensors on a single microscale device.
The team includes original inventors of the core technology from California Institute of Technology (Dr.
Nazari, Dr. Rahman, Mr. Sencan), seasoned and respected researcher in Glucose sensor technology
(Bill Van Antwerp, former CSO of Medtronic MiniMed), surgery and biomaterials expert (Dr. Jonathan
Lakey of UC Irvine), regulatory and IP expert (John Heithaus, JD), commercialization expert (Mr. Peter
Rule; former President of MiniMed, Chairman of Therasense, and OptiScan), and clinical expert (Dr.
Alan Marcus, MD; former Chief Medical Officer of Medtronic Diabetes). The project is supported by
patient advocacy groups like JDRF and practicing endocrinologists like Dr. Anne Peters.

Public health relevance
Project Narrative In this application, we propose to enhance our current miniature (smaller than half a sesame seed) wireless Continuous Glucose Monitor (CGM) into a wireless Continuous Diabetes Monitor (CDM) by adding ketone sensing capability without increasing its size. This would require designing two working electrodes, two potentiostats, a multiplexer, and two functionalization wells on the IMS electrochemical sensing platform, developing functionalization techniques for two enzymes, updating the transmitter firmware (to decode multi-sensor data), and reader software (to read, display, and store multi-sensor data). We have performed feasibility studies to verify that the proposed design has very low risk. Domain experts and patient advocacy groups have shown keen interest in the system. NIH support is essential at this stage for enablement. IMS CMOS CGM System on a US quarter (IMS CDM platform would be similar)